FACTORS LIMITING LEAN BODY RESPONSE TO NUTRIENTS &OTHER ANABOLIC THERAP IN AIDS

The objectives of this study are to establish the role of primary and secondary hypogonadism in the predominant fat accumulation observed with megestrol acetate therapy in AIDS wasting.